Air Pollution and Cardiovascular Disease in American Indian Communities

ABSTRACT
Increasing evidence indicates that air pollution is a relevant risk factor for cardiovascular disease (CVD) even
at low exposure levels. American Indian populations experience the highest burden of CVD compared to other
racial/ethnic groups in the US and thus may be particularly vulnerable to air pollution. Further, although air
pollution exposure levels have decreased in recent decades in the general US population, these decreases are
less pronounced in American Indian populations, suggesting environmental disparities in air pollution
mitigation. However, there is currently a lack of relevant data to comprehensively characterize air pollution
levels, components, and sources in American Indian and other rural populations, which are needed to inform
effective mitigation and intervention strategies. We propose to study the associations of air pollution exposure
with CVD as well as with subclinical risk factors for CVD (blood pressure) in American Indian communities in
the Southwest and Great Plains. We will leverage data from the NHLBI-funded Strong Heart Study (SHS)
cohort to study short-term and long-term cardiovascular effects of air pollution in American Indian communities.
Aim 1: We will characterize ambient air pollution via measurements and spatio-temporal modeling in the three
SHS study regions (Arizona, Oklahoma, North and South Dakota). For four years, we will use filters and
pumping boxes at a central site in each study region to obtain two-week average concentrations of ambient
fine particulate matter (PM2.5) and its components including black and organic carbon, metals, and acids. We
will also obtain two-week averages of ozone (O3) levels using passive samples. In a subset of 240 SHS
participants (80 per region) in three different seasons, we will measure ambient real-time PM2.5 levels for one
week. Our measurements and other available PM2.5, nitrogen dioxide (NO2), and O3 data will be used to build
spatio-temporal air pollution models for SHS regions. Source apportionment will be used to identify pollution
sources. Aim 2: We will determine short-term cardiovascular effects of air pollution exposure in these
communities. We will evaluate associations between ambient PM2.5 levels and composition, NO2, and O3 (from
Aim 1) with measures of ambulatory blood pressure monitoring in 240 SHS participants in three repeated
measurements over 18 months. Aim 3: We will determine long-term cardiovascular effects of ambient air
pollution exposure. We will evaluate associations between long-term exposure to PM2.5, NO2, and O3
(estimated with our model in Aim 1) and incident CVD (coronary heart disease, stroke, heart failure) in the SHS
cohort (N = 2,736) and its family expansion (N = 2,769) using high-quality data for 2000–2024. This study will
comprehensively characterize air pollution exposures and associations with clinical CVD outcomes in
American Indian and rural populations. Our data will provide critical data needed to inform National Ambient Air
Quality Standards, ultimately contributing to strategies to mitigate the adverse health effects of low-level air
pollution exposures especially in already vulnerable populations including American Indians.

Public health relevance
NARRATIVE American Indian populations experience the highest burden of cardiovascular disease compared to any other racial/ethnic group in the US and thus may be particularly vulnerable to the adverse health effects of even low levels of air pollution; however, there is currently a lack of relevant data to comprehensively characterize the air pollution levels, components, and sources in American Indian and other rural populations. Leveraging the NIH- funded Strong Heart Study, we will characterize air pollution and its association with cardiovascular disease in American Indian populations in the Southwest and the Great Plains. This study in rural and American Indian communities will provide critical data that are currently missing to inform National Ambient Air Quality Standards, contributing key information needed to inform interventions and mitigation strategies to reduce air pollution exposures and improve overall health of vulnerable populations.